Impact of drugs of abuse on HIV brain reservoirs and HAND in humanized microglia mice

ABSTRACT
Since the start of the HIV/AIDS epidemic, it has been recognized that drug abuse is strongly linked to contracting
and transmitting HIV, as well as more severe consequences. Factors influencing the susceptibility and disease
progression are still unclear. Viral reservoir establishment occurs early in acute HIV infection and reaches a set
point within the first two months of infection, which in turn determines the size of the reservoir in the chronic
stage. HIV enters the brain right after infection and replicates in macrophages, microglia, and to a small extent
in astrocytes. Increased susceptibility in substance use could affect the size of the central nervous system (CNS)
reservoir, which may influence spontaneous virological remission and viral rebound kinetics. CNS viral reservoir
size may also determine the HIV- associated neurocognitive disorder (HAND) severity, viral recurrence, and
rebound. Until now, there was no means to study the viral dynamics, CNS viral invasion, susceptibility to MP
infection in the brain, and the reservoirs of HIV infection so that interventions can be developed effectively. A
small animal model, like the humanized mouse, provides great advantages due to manipulations using
host/human cells, as well as the possibility of establishing chronic infection by HIV itself. The humanized
microglial (hMGL) mouse model is reconstituted with the human immune system and human glial cells, which
allows natural progression of CNS infection and disease in relation to peripheral HIV infection. Herein, we
propose to deploy our hMGL mouse to elucidate the mechanisms of HIV-1 invasion, persistence, and
neuropathogenesis for substance use. Our objective is to define the CNS viral reservoir and investigate changes
in the brain viral reservoir as a consequence of substances of abuse with an overarching goal of viral eradication.
Our aims are, 1. to investigate the effect of cocaine on the CNS viral invasion, reservoir establishment, and viral
latency during chronic infection in humanized microglial mice, 2. to determine the host genetic signatures that
accelerate the CNS viral reservoir and assess the influence of antiretroviral therapy (ART) on glial homeostasis,
and 3. to study HIV and SUD-induced neuropathology using a multimodal approach. The complete
characterization of this humanized mouse model in establishing linkages to human disease, and demonstrating
a comprehensive evaluation of the CNS reservoir during cART, HIV infection, and drug abuse will prove to be a
significant value to the neuroHIV field.

Public health relevance
NARRATIVE The proposed research is significant because it will provide a critical step forward in the development of a humanized glial mouse model of NeuroAIDS that can mirror human disease. Natural progression of brain infection and disease in relation to peripheral HIV infection makes this mouse model most relevant for the studies of viral reservoir assessments, neuropathology, and therapeutic development including eradication strategies. These mice are important tools to study the role of substances of abuse on viral reservoirs and HAND.